STUDY OF ORAL ISOBUTYRAMIDE INCREASING FETAL HEMOGLOBIN IN BETA GLOBIN DISORDERS

The objective of the research described in this proposal is the amelioration of the clinical severity of hemoglobin disorders such as beta-thalassemia and sickle cell disease by increasing the production of fetal hemoglobin.